Mechanisms required to compartmentalize the stem cell niche during organogenesis.

Project Summary/Abstract:
Stem cells are required for tissue homeostasis and regeneration. Accomplishing these tasks often requires
intimate association between stem cells and their niche, where stem cells efficiently receive critical niche-
derived signals within specialized tissue compartments. These niches are formed by cells that often must
migrate during organogenesis to attain their appropriate position, yet how this morphogenesis is achieved is
unclear. The broad objective of this application is to define – using powerful genetics and incisive optogenetic
approaches in an accessible undergraduate model system – the molecular mechanisms dictating embryonic
establishment of the Drosophila male testis niche. Results from this work will reveal the cellular dynamics and
molecular mechanisms required to assemble a functional model stem cell niche, which are likely to be
applicable to the numerous other stem-cell based tissues. Our previous work showed that Slit and FGF signals
from adjacent visceral muscle are required to assemble the testis niche. In response to these signals, niche
cells express the transcription factor islet, which is required for F-actin polarization and movement to the gonad
anterior. In Aim 1, we will examine key signaling intermediaries required to induce islet expression in response
to gonad extrinsic signaling. In Aim 2, we will define downstream mechanisms that mediate islet function and
pursue predicted islet targets expressed in niche cells. Using an optogenetic approach during in vivo live
imaging, we will also investigate niche cell behaviors reliant upon mechanisms regulating the F-actin
cytoskeleton. In Aim 3, we will identify how niche-extrinsic signaling from another tissue within the gonad
positions the forming niche. Concepts we elucidate will have broad applicability to studying normal
development, promoting success of stem cell replacement therapies, and revealing mechanisms by which
cancer cells often shape their unique tumor microenvironments. Furthermore, funding from this proposal will
support infrastructure at a large regional public university where we will employ a tractable model system that
provides high-impact biomedical research experiences to underserved undergraduates in a supportive training
environment.

Public health relevance
Project Narrative: The positioning and architecture of a stem cell niche is crucial to the niche's ability to maintain stem cells and thus, to maintain appropriate tissue renewal during injury or aging. The mechanisms by which niches are assembled, however, remain poorly characterized. Using a powerful genetic model, this proposal will investigate the molecular mechanisms required to assemble a stem cell niche, which is required for development and maintenance of functional biological tissues.